Biomechanics Core Facility

Articular cartilage functions as a bearing surface in freely moving joints such as hip and knee. It provides a low friction surface with excellent wear characteristics, it helps to distribute joint contact loads over a larger area than would be present if there was bone-to-bone contact, and it performs these functions while loaded at several times body-weight. Tissue engineered cartilage must be able to perform the same mechanical functions as native tissue. The Biomechanics Core Facility will provide material testing and general biomechanical expertise for evaluation of tissue-engineered constructs. Material properties will be determined using widely accepted test methods and models. Functional aspects of the repair will be investigated using specialized tests. In addition to supporting PROJECTS I, II, and III, biomechanical investigations will benefit from imaging capabilities of the Morphology core.